Non-human Primate Immunogenicity Studies of HIV-1 immuno

Several ongoing macaque studies are evaluating the DNA prime, rAd boost vaccine strategy. Preliminary data show that DNA immunization can elicit cellular and humoral immune responses that are substantially boosted by rAd immunization.